ADMINISTRATION

The objective of the Administrative Core proposed in this Program Project is to assist the Program Director in providing budgetary, organizational, and secretarial support to the Principal Investigator, co-investigators, and staff responsible for the three projects and three cores described in this application. During the proposed grant period, the Administrative Core will be responsible for the preparation of manuscripts for publication, budgetary management, and reporting of the allocated funds, assistance to the investigators with the hiring of new personnel and ensuring compliance with the University of Miami hiring practices, and purchasing of supplies and materials for the various projects and cores. The Administrative Core will be responsible for the coordination of periodic meetings of the investigators to review data and organizational activities related to the research proposed in this grant. This core will also coordinate visits from the External Advisory Board once each year. The core will be directed by Program Director, W. Dalton Dietrich, PhD. The day to day administrative activities of this program project grant will be handled by the Executive Assistant, Jeremy Lytle. Grant Manager, Jon R. Vega, will assist Dr. Dietrich in the business and flscal portion of these activities.